Employing biofilters to detect human pathogens in Mid-Atlantic US waters

PROJECT SUMMARY
Throughout the United States, human populations in coastal zones have been steadily increasing.
Additionally, humans partake in many aquatic recreational activities and consume significant amounts
of seafood either farmed or harvested from coastal waters. All of these activities increase the diversity,
dispersal, and transmission potential of human pathogens. Unfortunately, knowledge of the
environmental epidemiology of human pathogens in coastal waters is limited. Tools capable of
generating high-resolution information are needed to determine the sources, connectivity, and spatial
distribution of these organisms in coastal environments. This project proposes the design, optimization,
and utilization of a set of in-solution sequence capture arrays to conduct targeted enrichment of viral and
bacterial human pathogens to determine their diversity, distribution, dispersal, and connectivity in
coastal waterways. Both capture arrays will utilize existing genomic resources to create the arrays,
which will include a mixture of shared and unique loci. Using a variety of conserved and variable loci
from these pathogens allows us to capture genomic regions useful for comparative studies across taxa
(shared loci) and for population genomic studies (unique loci) within taxa. The efficiency, sensitivity,
and specificity of the designed capture arrays will be assessed by testing these arrays on samples from
biofilters, which will be market-sized oysters deployed downstream from wastewater treatment
facilities. The data generated from this project will be used to conduct preliminary environmental
molecular epidemiological studies on these parasite taxa across spatial and temporal scales. This
information is critical for public health officials to make informed decisions about the health and safety
of humans using, living near, and consuming food resources from coastal waters.

Public health relevance
PROJECT NARRATIVE The proposed research involves the development and utilization of a novel capture array for molecular environmental epidemiology studies through simultaneously targeting thousands of loci across the genomes of multiple bacterial and viral pathogens that cause disease outbreaks in human populations. Through this and future studies, the proposed methodology has the potential to greatly increase our fundamental knowledge of the ecology, spread, and transmission of these pathogens in coastal environments. Consequently, this essential information can be used to reduce illness associated with recreational water usage and seafood consumption.